Leadership, Planning and Evaluation

LEADERSHIP, PLANNING AND EVALUATION (LPE)
PROJECT SUMMARY/ABSTRACT
Responsibility for planning and evaluation activities at Rutgers Cancer Institute rests with Center
Director, Steven K. Libutti, MD, FACS, who sets the vision for and leads Strategic Planning,
participates in evaluation activities, and directs and supports Strategic Plan enhancements. The
reporting period for this application spans our previous and current Strategic Plan. These
Strategic Plans drove Cancer Center evolution and accelerated progress toward achieving our
research vision, stability through tremendous growth and change, increased research
collaborations, impact on catchment area, and improvements in training and education. Our
Senior Leaders (Center Director – Steven Libutti, Deputy Director – Eileen White, and Associate
Directors for Basic Research – Zhiyuan Shen; Clinical Research – Howard Hochster; Population
Science and Community Outreach – Anita Kinney; Translational Research – Shridar Ganesan;
Consortium Research – Yibin Kang; Education and Training – Edmund Lattime; Shared
Resources – Adam Berger; and Administration and Planning – Linda Tanzer) each have welldefined
roles and work collaboratively to drive scientific progress that addresses the needs of our
catchment area. Our primary advisory bodies, which include our External and Internal Advisory
Boards, Consortium Steering Committee, and Community Cancer Action Board (CCAB), engaged
key stakeholders and provide valuable insights in alignment with the Strategic Plan. Selected
achievements of Leadership include: 1) launch of a new five-year Strategic Plan with a vision and
core values enhanced by communication with the new CCAB; 2) expansion of the role of our new
Associate Director for Community Outreach to incorporate oversight of Population Science; 3)
recruitment of a new Associate Director and Assistant Director for Shared Resources and
development of an Office of Shared Resource Management; 4) 93% increase in accruals to
interventional therapeutic studies with statewide impact; 5) growth in the cancer institute’s
signature efforts in immunology and metabolism to include establishment of a new Immunology
and Metabolism center, a developing Cellular Therapy program, operationalizing a GMP facility,
strengthening the Cancer Metabolism and Immunology Research Program through better
integration of the immunology aim, and accelerating cancer metabolism research with Princeton
University, including a joint partnership in the new Ludwig-Princeton Branch; 6) establishment of
the Immune Monitoring Core as a new Shared Resource; and 7) expanding our cancer screening
initiative for underserved regions of our catchment area. These achievements contributed to an
increased cancer focus, shown by the 22% growth in peer-reviewed cancer-focused funding.

Public health relevance
PROJECT NARRATIVE Not required per PAR-21-321 (Cancer Center Support Grants (CCSGs) for NCI-designated Cancer Centers (P30 Clinical Trial Optional)